Research Supplement - Luz Andrino

Project Summary
Age-related hearing loss is exceedingly common, with an estimated 60% of individuals over 70 years of
age having hearing loss significant enough to interfere with communication and affect quality of life. However,
increasing evidence suggests that the overt loss of hearing thresholds alone fails to capture real-world hearing
difficulties experienced by older adults. One hitherto undiagnosed cause of hearing deficits could be the
progressive loss of synapses between the inner hair cell and the auditory nerve with age, termed cochlear
synaptopathy. Cochlear synaptopathy is thought to affect speech intelligibility under complex listening conditions,
yet it goes undetected by the threshold audiogram, remaining ‘hidden’. While the functional consequences of
cochlear synaptopathy are still unclear, emerging evidence suggests that it is associated with deficits in
representation of timing cues in the auditory periphery. This may differentially affect the encoding of rapid
stimulus temporal fine structure (sTFS) cues in speech, which are critical for listening in noisy conditions.
Establishing the effects of cochlear synaptopathy on decreased speech-in-noise intelligibility cannot be
accomplished in a single species. Perceptual deficits observed in humans cannot be attributed directly to
cochlear synaptopathy, because anatomical synaptopathy is only verifiable in post-mortem specimens. Rodent
models offer the means to directly measure cochlear synaptic integrity but are limited in their potential to serve
as models of human speech perception under real-world settings. This proposal addresses these translational
challenges by integrating research in humans and animal models, with non-invasive electrophysiological
responses measured under near identical conditions in both humans and animal models acting as the
translational bridge. Experiments in Aim 1 will use a battery of behavioral and electrophysiological methods in
humans to test the hypothesis that degradations in speech-in-noise intelligibility with age are accompanied by
altered neural coding of sTFS cues. In Aim 2, the role of age-related cochlear synaptopathy in degraded sTFS
processing will be studied in an animal model whose hearing range is sensitive to human speech frequencies,
using the electrophysiological biomarkers of sTFS processing validated in humans. Aim 3 will isolate
contributions of cochlear synaptopathy to the neural coding of sTFS cues from possible confounding age-related
effects by inducing graded synaptopathy in young animals and evaluating the same electrophysiological and
immunohistological markers used in Aim 2. The completion of this project has the potential to result in a single
biomarker that links cochlear synaptopathy to deficits in speech-in-noise intelligibility. The project will further
establish an integrated research pipeline that can accelerate the translation of pre-clinical studies to early human
trials for future biomarkers or interventional therapies. Finally, the data obtained here will form the basis for future
studies that will follow this translational approach to explore the interactions between age-related cochlear
synaptopathy, peripheral threshold sensitivity, and compensatory plasticity in the central auditory pathway.

Public health relevance
Project Narrative Hearing difficulties with age may be due to the progressive loss of nerve connections in the inner ear, but this loss does not show up in current clinical tests. The proposed study will integrate research in humans and an animal model with human-like hearing, to develop new diagnostic tests for this ‘hidden’ hearing loss. The completion of this study could lead to novel diagnostic tests that can be used to detect this loss of inner ear nerve connections in the clinic, all while setting up a translational research pipeline to develop future diagnostics and test therapies for various forms of hearing loss.